Shared Resources Management

SHARED RESOURCE MANAGEMENT: ABSTRACT
The University of Florida Health Cancer Center (UFHCC) members benefit from access to the UFHCC-managed
Biostatistics and Quantitative Sciences Shared Resource (BQS-SR) and the institutionally-managed Flow
Cytometry and Confocal Microscopy Shared Resource (CYT-SR) and Next Generation Sequencing Shared
Resource (NGS-SR). With nearly 25 years of experience in shared resource management, Madore (ZY),
UFHCC Associate Director for Shared Resources and UF Interdisciplinary Center for Biotechnology Research
Associate Director for Science, manages the shared resources (SR) to drive novel discoveries through member
access to cost-effective, leading-edge instrumentation, and quantitative science expertise. The SR Management
goals are to: 1) identify and evaluate SR needs of the membership to support existing centralized SRs and
develop new SRs; 2) establish standard operating procedures, facilitate regular staff training, and assure quality
control processes for rigor and reproducibility of research; 3) leverage existing institutional resources to create
and expand services and continuously evaluate new technologies to meet member needs; 4) monitor
effectiveness of SRs through membership surveys and advisory oversight groups; 5) establish and maintain
policies for optimal SR capacity and maximal access; and 6) centralize fiscal planning and billing management
systems in compliance with institutional and federal policies. SR funding comes from an established chargeback
system, institutional resources, direct grant support, and strategic partnerships with the UF Office of Research
and UF Colleges. A member of the UFHCC Executive Committee, Madore chairs the UFHCC SR Oversight
Committee that supervises SR Management in alignment with the UFHCC Strategic Plan. Scientific Advisory
Groups for each SR provide faculty-guided feedback and advice. Since 2016, UF institutional commitment for
SRs includes salary subsidy for 9 staff members in the institutionally-managed CYT and NGS-SRs and $1.5M
in capital equipment investment. Leveraging this continuous support, UFHCC contributed $1.7M for
instrumentation acquisitions and enhancements in CYT-SR and NGS-SR. UFHCC recruited 6 new
biostatisticians and bioinformaticians in the BQS-SR (~$1.4M investment to date) and supported a PhD
immunologist in the CYT-SR to perform flow-based immunophenotyping for a first-in-human therapeutic tumor
RNA vaccine trial. Since 2016, the BQS-SR, CYT-SR, and NGS-SR contributed to 574 cancer-focused
publications (19% with impact factors ≥10) and supported $117.4M (direct costs, all years) in peer-reviewed
grants. Since 2016, 222 UFHCC users accessed BQS-SR, 78 utilized CYT-SR, and 54 utilized NGS-SR. Future
plans, in alignment with the UFHCC strategic plan, Momentum 2027, include expanding the SR services
portfolio through acquisition of new instrumentation and technology (e.g., spatial transcriptomics, super high-
resolution microscopy), supporting BQS-SR in implementing artificial intelligence/machine learning methods,
and leading the formation of two UFHCC developing SRs in response to membership needs.